Dynamic RNA modifications that control gene expression in diabetes

Project Summary
Genetic and environmental factors play important roles in the etiology of diabetes. How these factors interact to
promote disease remains unclear. N6-methyladenosine (m6A) is a dynamic mRNA modification that can direct
splicing fate and stabilization, promote translation of mRNAs, and integrate nutritional information. Drosophila
melanogaster, flies, with lowered levels of m6A in insulin-producing cells (IPCs) are diabetic; this phenotype is
exacerbated by exposure to a nutrient-rich diet. mRNAs that encode proteins in the insulin system are
methylated in the brain of flies. These results suggest that m6A plays a critical role in the insulin system. Yet,
the mechanisms through which m6A contributes to the development of diabetes are unknown. The power of
Drosophila genetics, the anatomy of the IPCs, the relative simplicity of the system, and the recent development
of direct RNA-sequencing will be leveraged to uncover mechanisms through which m6A controls gene
expression in IPCs. The central hypothesis is that reduced m6A in IPCs impairs necessary dynamic
translational control over the insulin system. Aims 1 and 2 (K99) will focus on cell-intrinsic mechanisms that are
sensitive to the loss of m6A regulation. These will uncover cell biological properties that depend on m6A for
proper insulin output. Aims 2 and 4 (R00) will probe cell-extrinsic factors, which require m6A, that integrate
external inputs. These will elucidate how m6A impacts insulin receptor translation and how the levels of m6A
respond to nutritional state. Together, this proposed work will define a role for m6A methylation of mRNA in the
function of IPCs and reveal how metabolic inputs modulate m6A control over mRNAs. This will advance our
understanding of RNA control and may facilitate the discovery of therapeutic targets for diabetes prevention
and therapy.

Public health relevance
Project Narrative N6-methyladenosine (m6A) is a dynamic mRNA modification that can specify splicing fate, destabilize, and promote translation of mRNAs. Here I will dissect how m6A contributes to gene expression in insulin-producing cells through the incorporation of cellular signals and nutritional information. Our findings will define the role of m6A in the etiology of diabetes, which may facilitate the identification of new molecular targets for therapy and prevention of metabolic disorders.